Developing a Rapid, Simple-to-use Sensory Platform for Detection of Ultralow Concentration of SARS-CoV-2 Viral Particles Enabled by Electrophoretic Enhancement and Redox Cycling

Abstract: COVID-19 caused by the severe acute respiratory syndrome coronavirus-2 (SARS-CoV-2) remains an extraordinary global health crisis in the modern history. Meeting the testing needs for clinical diagnosis remains an unmet global challenge. Simple-to-use, sensitive, and rapid diagnostics are therefore urgently needed for early diagnosis of infection. The objective of this research is to design and demonstrate proof-of-principle of a novel low-cost and simple-to-use electrochemical sensing platform to enable rapid, ultrasensitive and accurate detection of SARS-CoV-2 virions in saliva (with accuracy ? 90% and total assay time < 30 min). We propose to achieve high sensitivity through two complementary signal amplification schemes, by electrophoretic concentration of virus-magnetic nanoparticle (mNP) conjugates by applying a small voltage on a set of electrodes with sub-micrometer gap, and amplifying electrochemical current through redox cycling between the same set of electrodes. Importantly, the proposed platform is suitable for commercialization by leveraging a low-cost and scalable fabrication method to create the sensor arrays without using expensive and non-scalable nanofabrication techniques. Fast, sensitive, and accurate detection of viral particles enables better surveillance and control of spread of the infection. The proposed platform is simple-to-use and suitable for point-of-care applications by eliminating tedious RNA extraction steps as in RT-PCR methods. It can enable high-throughput testing by creating sensor array on the same chip with small footprint to simultaneously analyze a multitude of sample droplets. The proposed sensory platform can also be expanded to detect other infectious pathogens, including Dengue and Influenza viruses, bacterial pathogens, etc.

Public health relevance
Project Narrative Simple-to-use and accurate diagnostics are urgently needed for early detection of SARS-CoV-2, the causative pathogen of the 2019 novel coronavirus disease. We propose to develop and demonstrate proof-of-principle of a novel simple-to-use, accurate, and rapid electrochemical sensory platform for detection of SARS-CoV-2 virions in saliva by leveraging two signal amplification methods: namely electrophoretic-enabled concentration of virus-magnetic nanoparticle conjugates and redox cycling of electrochemical signals through an array-formatted design.